TAS::75 0893::TAS HIGH PRECISION WEB-BASED COGNITIVE MEASURES

The tests will be published to our company website where they can be run by anyone with a Windows PC and access to the web. Data from these test runs will be recorded and saved to a secure location Millisecond web server. The source code for the scripts will be made available for download.